Parallel Pressure Reactor with Sampling Capabilities

PROJECT SUMMARY/ABSTRACT There is a strong need for instrumentation optimized for studying catalytic reactions under various pressurized atmospheres including (but not limited to) air, hydrogen, carbon monoxide, carbon dioxide, and sulfur dioxide. Ideally, the system should be able to take reaction aliquots without disrupting a pressurized atmosphere. The Freeslate Jr. robotic platform configured with an OSR module (Unchained Labs) is uniquely capable of addressing these needs. The OSR module allows eight parallel reactions to be run with independent temperature and pressure control. It differs from other parallel pressure reactors with similar specifications in that it can take reaction aliquots without disrupting the reaction atmosphere. This allows much faster reaction optimization and kinetics studies since disrupting the pressurized environment often deactivates the catalyst;? without the Freeslate Jr. with OSR it often is necessary to set up a separate reaction for each timepoint. This not only wastes a lot of time as compared with obtaining reaction aliquots from multiple timepoints in a single pass, but also wastes a lot of precious materials (e.g., reactants and custom ligands). The experiments supported by the proposed instrument will allow much more rapid development of organic reactions that are broadly useful in medicinal chemistry, process chemistry, and chemical biology. These reactions include fragment couplings, functional group installation, and isotopic labeling reactions. These reactions are likely to find immediate applications in the pharmaceutical sector in all stages of drug discovery and development.

Public health relevance
PROJECT NARRATIVE Many chemical reactions used in the preparation of drugs and biological probes require pressurized reaction conditions. These reactions often are difficult to study since they are not readily followed due to reaction setup limitations. The proposed instrument will significantly accelerate the optimization and mechanistic study of such reactions.